Preventable Differences: Exploring Public Health Careers with Black and Latino Youth

Project Summary / Abstract
The overarching goal of this project is to create exhibits and programs that educate broad
audiences, especially Black and Latino adolescents and young adults, about public health
careers and their role in alleviating the inequitable health outcomes that Black and Latino
communities suffer from. We will use the COVID-19 pandemic as the content focus for these
exhibits and programs. Key learning outcomes will include:
1. COVID-19 and other health challenges have had a disproportionate impact on Black and
Latino people, for a variety of interconnected reasons;
2. Minimizing this disproportionate impact will require creating locally-tailored,
culturally-responsive public health interventions and engaging community-level public
health experts to recruit and support public participation;
3. There are many health- and medicine-focused career pathways that young people can
pursue that can help them contribute to the goal of better protecting vulnerable
communities from future epidemics and pandemics.
The specific aims of this five-year proposed project are to:
1. Project Years 1-2: Engage public health experts and community members from Queens,
NY in a range of public events to build trust, gather input, track the latest emerging
scientific knowledge COVID-19 and effective tracing, diagnosis and treatment; and guide
the design and development of exhibits and workshops that address project goals.
2. Project Year 3: Fabricate five exhibit pieces and create a career exploration workshop
series that address these goals, pilot them at the New York Hall of Science, evaluate
their impact and revise as needed.
3. Project Year 4: Pilot the exhibit pieces and workshop series at a peer science center in
Oakland, CA, evaluate their impact and revise as needed.
4. Project year 5: Produce final versions of the exhibit pieces for the New York Hall of
Science; disseminate exhibit plans for use at other museum sites; disseminate workshop
formats for use at other museum sites; disseminate evaluation findings.
The project will use formative testing and prototyping to inform the design and development of
educational resources. The project evaluation will use culturally-responsive, rigorous methods to
both monitor project progress and quality and to test the impact of project deliverables on
participants and public audiences.

Public health relevance
Project Narrative The proposed project will benefit society by helping Black and Latino youth who live in communities facing multiple, intersecting health inequities, and have most recently been disproportionately affected by COVID-19, to discover how public health professionals contribute to protecting vulnerable communities from future epidemics and pandemics and how they can pursue specific public health- and medicine-focused career pathways. The proposed project will engage the New York Hall of Science with scientists and public health experts from local hospitals and universities, as well as community youth and leaders from a local community-based organization, to collaboratively develop strategies for educating the public about the role of public health in addressing long-standing obstacles to positive health outcomes for Black and Latino populations. The proposed project will create exhibits and programming that can be scaled to a wide variety of informal STEM learning institutions and help broad audiences better understand the roles that they and public health experts can play in mitigating the impact of future health crises in their own communities and in others suffering from poor health outcomes.